NHGRI Research Training and Career Development Annual Meeting

Summary
The National Human Genome Research Institute (NHGRI) provides support for trainees from the
undergraduate to the post-doctoral level in the fields of genome sciences, medicine and ethical, legal
and social implications. The annual Research Training and Career Development meeting is a venue for
NHGRI trainees to present their research and learn about other research and programs, to network and
begin to develop collaborations with other trainees and faculty, and gain experience of attending
professional scientific conferences (this will be the first professional meeting for some trainees). Duke
University was selected to be the coordinating center for the annual training meeting (#3 R13-
HG011814-01S1) Duke will provide continued support for this excellent annual event for trainees and
strive to enhance the impact, learning efficiency and networking opportunities with new and innovative
technologies to address the changing landscape, in part brought on by COVID19. This administrative
supplemental request will provide travel support for advisors to attend the meeting and for trainees
that do not have travel funds available through their award (Fellowship and Diversity supplement
awardees).

Public health relevance
Public Health Relevance The purpose of this administrative supplement is to provide travel support for advisors and trainees to attend the annual Research Training and Career Development meeting that are not part of program that otherwise would cover the costs of attending the meeting. The supplement aligns with the aims of the parent award to coordinate and carry out the annual meeting and other activities for trainees. The success of this proposal will help maximize attendee and facilitate trainees development and education.